The BRCA Exchange Knowledgebase for Clinical Cancer Genetics

PROJECT SUMMARY / ABSTRACT
Heritable Breast, Ovarian, Pancreatic and Prostate (HBOP) cancers arise from pathogenic variation in
cancer susceptibility genes, including BRCA1 and BRCA2. The average woman in the United States faces a
12% lifetime risk of breast cancer, but this number rises to roughly 66% for women who carry pathogenic
variants in the BRCA1 or BRCA2 genes. These variants also present a 44% lifetime risk of ovarian cancer,
compared to a 1.5% risk for women on average. Individuals who carry a pathogenic BRCA variant can
manage their cancer risk clinically, often avoiding cancer entirely, but these clinical interventions are not
available to all individuals at risk. The majority of observed BRCA variants are Variants of Uncertain
Significance (VUS), individually rare yet collectively common variants for which there is insufficient evidence for
clinical classification. Additionally, one-fourth of the BRCA variants in ClinVar have conflicting classifications.
Sharing knowledge to promote accurate variant classification is key to reducing the burden of these heritable
cancers.
BRCA Exchange is the world’s largest public source of knowledge on variation in BRCA1 and BRCA2,
aggregating variants from repositories including ClinVar, gnomAD and LOVD, and annotating them with
pathogenicity evidence selected by the ENIGMA research consortium on HBOP Cancers and the ClinGen
ENIGMA (BRCA1 and BRCA2) Variant Curation Expert Panel. This resource is visited by more than 3,000
distinct users per month worldwide, with data incorporated into major cancer research platforms including
SOPHiA Genetics’ Alamut and the Barcelona Biomedical Genomics Lab’s Cancer Genome Interpreter. We
seek funding to maintain and expand BRCA Exchange to leverage and support new progress in clinical
genomics. We will 1) refactor the database to promote expansion while leveraging emergent variant
annotation standards, 2) leverage new open source resources to expand the data integration pipeline
sustainably, 3) continue formalizing the knowledgebase governance, 4) share provisional assignments of the
ACMG variant evidence codes to promote VCEP-compliant variant curation, 5) share research datasets to
leverage and support new scientific progress in HBOP variation, and 6) expand the scope to share variants for
seven related genes for which there is now abundant and growing clinical knowledge but no effective
knowledgebase.

Public health relevance
PROJECT NARRATIVE Harmful mutations in the BRCA1, BRCA2 and related genes increase the risk of breast, ovarian, pancreatic and prostate cancers, but if these mutations are detected, that cancer risk can be controlled. BRCA Exchange shares information on mutations in BRCA1 and BRCA2 to help researchers determine which mutations lead to increased cancer risk. We are proposing to expand BRCA Exchange with additional types of data, and to expand its scope to more genes.